RISK FACTORS FOR RACIAL DISPARITIES IN ADVERSE PERINATAL OUTCOMES AFFECTING AFRICAN AMERICAN WOMEN

The Overarching Goal for our project is to better understand the impact of environmental stressors (i.e., due to demographic, socioeconomic, and/or psychosocial stress) on the incidence of gestational poor sleep quality that we predict triggers adverse pregnancy outcomes (APO; i.e., gestational diabetes, preeclampsia, fetal growth restriction, premature delivery, hemorrhage, and stillbirths) more prevalent in African American women than Caucasian women. Our Central Hypothesis is that “High Levels of Psychosocial and Socioeconomic Stressors Alter Gestational Sleep Quality, Reduce Coping Response, and Impair Glucose Tolerance Resulting in Adverse Pregnancy Outcomes”. To test this, we will enroll 256 otherwise healthy pregnant (singleton) African American women (ages 18-40 years) and followed starting from 12-14 weeks of gestation. Thus, under Aim 1 we will qualitatively and quantitatively measure sleep quality coupled with evaluation of demographic, socioeconomic status (SES), and psychosocial stress (PSS). In Aim 2, we will assess how poor sleep quality affects physiological functions for the regulation of maternal nutrients (glucose, amino acids, lipids). We will collect blood and saliva samples and measure key hormones regulating metabolism (insulin, corticotropin-releasing hormone (CRH), free and total cortisol), and carrier proteins (CRH-binding protein, cortisol-binding globulins). Finally, in Aim 3, we will determine the association between poor sleep quality versus gestational diabetes, preeclampsia, and stress levels during gestation. Several interrelated clinical biomarkers will be quantified to verify the physical and health status of participants (i.e., hemoglobin A1c, cortisol, C-reactive protein, lipid panel, and comprehensive metabolic panel), respectively. Altogether, we expect to find that high levels of SES and PSS predispose African American women to gestational poor sleep quality and adverse pregnancy outcomes.

Impact and Innovation: This study will yield new knowledge on the impact of low socioeconomic status and psychosocial stress on gestational sleep quality and APO in African American women. This may partly account for the disparities in APO since African Americans typically deal with a heavy burden of psychosocial and socioeconomic stressors.-. Overall, the concept that gestational poor sleep quality is a potent risk factor able to ‘unbalance’ the intricate catabolic state that occurs in the second half of pregnancy is novel. If validated this will uniquely inform screening tests for early detection of poor sleep quality during gestation and implementation of evidence-based non-drug strategies for the curtailment of disparities in APO.

Public health relevance
Our observational study will monitor and evaluate a cohort of pregnant African American women to better understand the correlation between environmental stressors (i.e., demographics, socioeconomic, and psychosocial factors) and poor sleep quality that we postulate portends adverse pregnancy outcomes (APO) more prevalent in African American women compared to Caucasian women. We expect to uncover new risk factors predisposing African American women to APO. This information will help guide the development of preventive and management strategies for curtailment of racial disparities in APO.